Administrative Core

ADMINISTRATION
PROJECT SUMMARY/ABSTRACT
Yale Cancer Center Administration encompasses the Office of Research Affairs, YCC Finance and Clinical Trials
Office, and Public Affairs and Communications, all of which work actively and collaboratively to support the
essential components of the CCSG in carrying out the YCC mission. Administration is responsible for 1) providing
efficient administration and management of essential CCSG functions; 2) facilitating and stimulating innovative
cancer research, training, and outreach activities; and 3) monitoring and evaluate Center finances and
administrative operations.
During the current project period, Administration made significant changes to improve workstreams. A core
facilities management system was implemented to manage and track Shared Resource usage requests,
equipment reservations, sample processing, billing, and invoicing. An improved database system to track
membership and publication data was adopted and a system was developed to track and monitor return on
investment for YCC’s internal grants program. All these changes allow for faster reporting of key Center metrics.
Administration plays a key role in planning and evaluation activities through the organization of advisory board
meetings and was instrumental in the development of the Strategic Plan. The 2023 -2028 Strategic Plan focuses
the Center’s efforts in five main areas including, 1) research, discovery and innovation; 2) reducing cancer burden
and disparities; 3) culture, equity and Inclusion; 4) training and career development; and 5) increasing access to
unsurpassed care. Administration is responsible for monitoring and tracking progress towards the Strategic Plan
and provides updates to leadership regularly.
An important goal of YCC is to promote high impact interdisciplinary cancer research. Administration contributes
to this goal by fostering collaborations through the organization of Research Program meetings, retreats and
administratively supporting the internal grants program. Over the current project period, cancer-relevant
research funding increased to $94.9M and NCI funding increased to $26.5M (+9.5%). YCC’s grant portfolio
includes three SPOREs, a UM1 and 10 U01 grants. The 305 YCC members published 2422 papers in the
current period, 30% of these were in high impact journals and 82% represent inter-institutional collaborations.
Administration’s efforts were key to supporting all these advances.
Future plans for Administration include re-evaluation of membership criteria, continue to work with Center
leadership to implement the Strategic Plan, support the newly launched Initiative to Address Disparities, and
foster high impact interdisciplinary cancer research by supporting the growing translational research
infrastructure.

Public health relevance
ADMINISTRATION – NARRATIVE Not applicable.